Community to Molecular Approaches in Early Screening and Diagnosis to Promote Equitable Outcomes Through the Continuum of Care in Cancer Among Populations of African Ancestry

PROJECT SUMMARY
The African-Caribbean Cancer Consortium (AC3) is a Global Oncology Program at Fox Chase Cancer Center
and plays a unique role by addressing cancer disparities involving African American, Caribbean and African
immigrants in the United States (U.S.) and their counterparts in native countries. AC3 membership is trans-
disciplinary (basic and population science researchers, clinicians, and cancer advocates) and consists of three
interconnected networks (U.S., Caribbean and Africa). Our 2023 conference theme: “Community to Molecular
Approaches in Early Screening and Diagnosis to Promote Equitable Outcomes Through the Continuum of Care
in Cancer Among Populations of African Ancestry” reflects the trans-disciplinary makeup of our membership.
Also, as we have achieved in prior conferences, our 2023 conference organizing committees, speakers and
audiences will fully reflect the diversity of our membership. In the U.S. and worldwide, cancer kills more Blacks
than any other racial/ethnic group. A great number of premature cancer deaths also occur in predominantly Black
nations in Sub-Saharan Africa and the Caribbean. Cancer research in Black populations remains profoundly
lacking not only in the US but also in Black dominant countries in Africa and the Caribbean. The number of
biomedical research publications from Africa and the Caribbean are increasing, but disparities remain for
research articles focused on cancer. Black scientists are also grossly underrepresented among NCI grant
recipients. Therefore, an international cadre of well-trained Black scientists increases the much needed diversity
among global cancer researchers. Considering the diversity of the U.S. Black population, cancer research in the
Caribbean and Africa is inclusive and also essential for addressing cancer disparities in the U.S. This equitable
approach to research will be most beneficial in the U.S. as these studies are critical to inform and improve
interventions, treatment and prevention of cancers among all U.S. Blacks. The AC3 Scientific and Training
Conference is therefore justified, timely and useful. Our cancer-focused training, scientific exchange and
collaboration planning workshops will be a boon to the AC3 efforts to accelerate cancer research, advance
careers of Black scientists and provides innovative opportunities to study cancer disparities that impact Blacks
in the US. The following are the Specific Aims: 1) To enhance diversity by providing professional development,
education and scientific training, to strengthen health disparities research, skills and competencies among
underrepresented and underserved early stage investigators and students. 2) To facilitate knowledge exchange
of the science of cancer among African-descent populations, and increase research development and the
coordination of research studies in Black populations. 3) To promote health equity by providing scientifically
rigorous, and clinically and culturally informed research for greater community benefit in order to improve
knowledge, awareness of cancer risk, strategies for cancer risk reduction and prevention.

Public health relevance
PROJECT NARRATIVE Our 2023 AC3 conference program builds on the AC3’s exemplary track-record in advancing global cancer research targeting Blacks who suffer the greatest from cancer mortality. This conference brings together transdisciplinary and multi-sectoral research partners to engage and plan for specific collaborative/team science research studies. Achieving this conference goal is enhanced due to a large volume of AC3 senior authored and seminal publications focused on cancer in Blacks, NIH and local funding, the requisite scientific expertise of speakers and mentoring experience of training faculty/mentors, the outstanding commitment of Institutional partners including FCCC and three renown institutions in Kenya, the diverse Black populations reached by our faculty, AC3 members and the relevance and impact of the AC3 to global cancer research and addressing Black cancer disparities.